Visual cortex circuits mediating arousal and visual discrimination

Project Summary: Arousal state transitions are evoked by unexpected or aversive stimuli that change the
context of the environment. These transitions prime the brain to be more alert to sensory input and optimize
sensory processing for goal-directed behavior. VIP neurons disinhibit excitatory neurons and are known to alter
excitatory sensory processing in response to top-down or neuromodulatory input. VIP neurons activate in
response to contextual changes and their activity increases during periods of increased arousal. However, it is
unclear how changes in arousal lead to VIP activation, or indeed if VIP neurons modulate sensory processing in
an arousal-state-dependent manner. Arousal state is controlled by norepinephrine (NE) release from the locus
coeruleus (LC), which fires in response to contextual change and projects to the cortex. LC-NE signaling is a
putative mediator of VIP activation following arousal state transitions, but this mechanism has never been
experimentally addressed. In this proposal, I will use the visual cortex as a model to test the hypothesis that
arousal state transitions modify cortical sensory processing through LC-NE mediated VIP activation to optimize
context-dependent goal-directed behavior.
Excitatory neurons in the visual cortex become more selective and reliable during increased arousal states. In
Aim 1, I will examine the role of VIP neurons in mediating these and other changes in visual processing by using
dual-wavelength two-photon calcium imaging to simultaneously record excitatory and VIP neurons during
different arousal states. I will then use optotagging to examine the temporal pattern of VIP activity as it relates to
changes in visual processing. I will then test if VIP-driven changes in visual processing mirror the effects of
arousal states on visual processing using optogenetic VIP stimulation. In Aim 2, I will examine the relationship
between LC-NE and VIP activity using optotagging, LC axonal imaging, and NE imaging. I will then test if LC-
NE stimulation drives VIP activation and alters visual processing using LC axonal optogenetics in V1. In Aim 3,
I will relate these findings to goal-directed behavior using a learned visual discrimination task. I will determine if
LC axonal and VIP neuronal activity are predictive of discrimination accuracy and improved excitatory encoding.
Finally, I will optogenetically activate or inhibit VIP neurons during the task to directly measure their contribution
to arousal-driven changes in discrimination accuracy. The Sur research group at MIT is an ideal environment to
pursue the research outlined in this proposal and to receive training that will prepare me for a career as an
independent investigator. I will have the opportunity to master technologies pioneered in the Sur research group,
including next-generation dual-wavelength two-photon imaging, optotagging, quantitative analyses of behavior
and its neuronal correlates, optogenetic manipulations, and computational analysis of neuronal populations to
examine changes in sensory processing and encoding. Taken together, the research project, training plan, and
research environment create a path to future independence well suited to my career goals.

Public health relevance
Project Narrative: Surprising or startling events activate the locus coeruleus, a region of the brain that controls arousal and is thought to aid subsequent perception and discrimination through modulation of sensory processing in the cortex. This modulation of the cortex is normally beneficial, but it can become dysregulated in disorders such as insomnia, depression, anxiety, and post-traumatic stress disorder. By exploring the mechanisms through which arousal shapes sensory processing, we hope to better understand the normal and pathological roles of arousal and highlight novel targets for therapeutic interventions.